Circadian control of neuroinflammation after spinal cord injury

PROJECT SUMMARY
Spinal cord injury (SCI) newly afflicts 18,000 Americans/year and has devastating effects on body function and
mental health. Initial spinal cord trauma elicits a delayed cascade of damage (“secondary damage”) that is driven
by a harmful inflammatory response. This delayed damage is a window for acute intervention, yet there are no
effective neuroprotective SCI therapies. Immune activation is broadly regulated by the circadian system, which
optimizes across-day physiologic activities. Importantly, pivotal circadian factors act as transcriptional regulators
that govern the circadian clock – but also control crucial processes in the body, such as immune reactivity. There
is a critical need to illuminate novel approaches for treating SCI, such as modulating the circadian-neuroimmune
axis, that could ameliorate anatomical and behavioral deficits. One promising circadian protein, REV-ERB, is a
transcriptional repressor that dampens reactivity of innate immune cells, including central nervous system mi-
croglia and peripheral macrophages. The overall objective of this proposal is to establish whether REV-ERB is
a circadian-neuroimmune repressor that can be targeted to improve neuroprotection and neurologic function
after SCI. Past studies show that SCI perturbs epicenter circadian rhythms, which likely enables excess inflam-
mation. Preliminary data reveal that activating REV-ERB reduces macrophage reactivity and boosts locomotor
recovery after SCI. Therefore, this proposal is important, as identifying new protective targets will help ameliorate
secondary damage and deficits after SCI. This proposal’s central hypothesis is that amplifying REV-ERB activa-
tion will improve neuroprotection, locomotor function, pain relief, and mood after SCI. The rationale is that re-
pressing harmful inflammatory transcriptional programs after SCI by boosting REV-ERBs will lead to neuropro-
tection, which would have implications for SCI therapies. This proposal addresses these Specific Aims: 1) Reveal
whether microglial and/or macrophage REV-ERBs are required to limit neurotoxic and neurologic detriments
after SCI; 2) Establish whether CNS macrophage-targeted REV-ERB overexpression improves tissue sparing
and neurologic recovery after SCI; and 3) Determine whether pharmacologic REV-ERB activation benefits in-
flammatory cell state to boost neuroprotection and SCI recovery. For the first time, this proposal combines field-
specific SCI and circadian-neuroimmune methods, including anatomical and molecular analysis of epicenter;
motor, pain, and mood-related behaviors; cell culture; and cutting-edge single-cell RNA-sequencing. Thus, the
proposed research is innovative, as it links unique ideas, expertise, and methods in SCI, circadian rhythms, and
neuroinflammation. This contribution will be significant: it will reveal the broad, clinically relevant role of optimizing
neuroimmune reactivity for improving neuroprotection – and for promoting locomotor recovery, pain relief, and
mental health – after SCI. Ultimately, this knowledge could inform development and implementation of novel
therapies for improving recovery and quality of life for those with SCI.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because spinal cord injury causes permanent disability and worsened quality of life. Targeting harmful neuroinflammation after spinal cord injury could lead to discovery of new therapies that improve tissue repair and functional recovery. This preclinical project aims to reveal the untapped therapeutic potential of the circadian-neuroimmune axis after spinal cord injury, and is therefore relevant to NIH’s mission to seek fundamental knowledge that improves health and reduces disability.